Structures and Properties of Polyglutamine Proteins and Their Aggregates

DESCRIPTION (provided by applicant): In spite of our knowledge of the Huntington's disease gene and of the disease mutations, and in spite of an enormous amount of creative work, the twin goals of a molecular level understanding of the disease mechanism, and the molecular therapy one hopes would emerge from this understanding, are not in reach. One difficulty holding the field back has been the unusual nature and unknown function of the disease gene product, a seemingly poorly behaved protein of over 3500 amino acids and no proven function. The full length Huntingtin protein has been very challenging to make and to work with, while the more manageable N- terminal fragment, exon1, though accessible by recombinant synthesis, is also poorly behaved in solution, especially when it contains a polyglutamine sequence in the pathological repeat length range of 37 or more. During previous terms of this grant, our group has taken a reductionist approach to this problem, working with peptide fragments that are accessible by chemical synthesis. Over the last funding period we moved from studies on simple polyglutamine (polyQ) sequences to studies of how the N and C-terminal flanking sequences of the polyQ in exon1 influence the solution conformation and aggregation of polyQ. These studies revealed a powerful and mechanistically complex accelerating effect by the 17 amino acid sequence on the N-terminal side of polyQ in exon1 (httNT) on polyQ aggregation along with a complete change in aggregation mechanism and the structures of the aggregated products. As part of our work to understand this effect, we developed the ability to produce chemically accessible analogs of htt N-terminal fragments (NTFs) related to exon1 that appear to behave similarly to authentic recombinant exon1, but at the same time are more manageable and amenable to introduction of small, well-defined probes for such techniques as NMR and FRET. In other recent work, we developed a staining method specific for amyloid forms of htt NTFs and polyQ in tissue and cells that has allowed us to visualize different aggregate structures in the cellular context. We also discovered, and engineered for cellular delivery, peptide-based inhibitors of different aggregation pathways of htt NTFs. In this renewal application, we propose to exploit these tools to reach a new understanding of the molecular events that are triggered by expanded polyQ in htt. The current wisdom in the HD field is that htt must be proteolytically processed to an N-terminal fragment as an early step in the disease mechanism. The physical state that NTF takes when it becomes toxic remains a mystery. This toxic physical state may be a misfolded form of the monomeric fragment, a short-lived aggregation intermediate, or a stable aggregate such as an amyloid fibril. In this proposal we will focus on structural analysis of monomers and stable aggregates, using chemically synthesized and recombinant htt NTFs including exon1, with biophysical tools such as NMR, fluorescence resonance energy transfer, hydrogen-deuterium exchange, and mutational analysis. We will also conduct a detailed study of the polyQ repeat length effect on the structure of the monomeric htt NTF as well as its aggregation propensity, and compare both to the repeat length dependence of HD risk. We will also explore the toxicities of these physical states by testing in vitro-produced materials and by probing the effect of inhibitors on htt-producing cells.

Public health relevance
PUBLIC HEALTH RELEVANCE: Huntington's disease is one of a family of genetic disorders leading to progressive neurodegeneration manifesting in loss of neuromuscular control, development of cognitive impairment and psychiatric conditions, and ending in death. Although there are some therapies that can provide comfort for particular symptoms, there are no known therapies that provide a cure or attack the central disease mechanism. Our project is aimed at improving knowledge about how the genetic mutation in Huntington's disease generates disease symptoms by focusing on the abnormal physical and cellular behavior of the protein Huntingtin that is altered by the mutation. Improved understanding of such molecular mechanisms of disease can be a powerful first step in developing effective treatments. PROJECT NARRATIVE Huntington's disease is one of a family of genetic disorders leading to progressive neurodegeneration manifesting in loss of neuromuscular control, development of cognitive impairment and psychiatric conditions, and ending in death. Although there are some therapies that can provide comfort for particular symptoms, there are no known therapies that provide a cure or attack the central disease mechanism. Our project is aimed at improving knowledge about how the genetic mutation in Huntington's disease generates disease symptoms by focusing on the abnormal physical and celular behavior of the protein Huntingtin that is altered by the mutation. Improved understanding of such molecular mechanisms of disease can be a powerful first step in developing effective treatments. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS Expansion of its polyglutamine (polyQ) segment to 37-40 glutamines confers toxicity leading to Huntington's disease (HD) onto the protein huntingtin (htt) and/or one or more of its proteolytically generated N-terminal fragments (NTFs). It is now widely accepted that one or more physical states of such toxic fragments mediate the gain of toxic function that is thought to be responsible for HD. One set of candidates are the mature aggregates, including amyloid fibrils, that accumulate as cellular inclusions in the neurons of HD patients and in cellular and animal models. Although their involvement is much debated, mature aggregates of htt NTFs are clearly polymorphic, and there is a strong possibility that those aggregates that are the most easily observed in cells and tissue are not necessarily the most toxic, disease-relevant aggregates. Another set of candidates are the oligomeric and protofibrillar intermediates in the aggregation of htt NTFs. These assemblies clearly exist, and are attractive alternative candidates for the toxic species. But their very brief existence in the aggregation of htt NTFs containing expanded polyQ sequences makes them extremely difficult to isolate in homogenous form in vitro and therefore to study. While these intermediates can be stabilized to some extent by working with htt NTFs containing short polyQ repeats, the relevance of this approach has been questioned since the work is with non-pathological repeat lengths. A third candidate for the toxic species is the hypothetical "toxic, misfolded monomer". It has been hypothesized that there may exist a misfolded monomeric htt species that undergoes a toxic interaction with a cellular target such as another protein. It's existence is inferred from the accumulation of aggregates of htt NTFs. That is, while aggregates are generated from this misfolded monomer, it is not the aggregates that are toxic - it is the misfolded monomer itself. While this is an interesting and feasible idea, until recently no conformational variability in any monomeric htt NTF has been directly observed. These candidates represent the HD molecular mechanism landscape in which the present application operates. In this application we want to use biophysical tools combined with some cell biology experiments to characterize the structures, stabilities, and toxic properties of those physical states of htt NTFs that we can isolate and study. The results are expected to provide an improved understanding of the biophysical and toxic properties of those species we are currently capable of isolating, and to also provide a rationale for future work to obtain for study disease-relevant forms of the species we currently have difficulties isolating. To address these long and short term goals we will pursue the following four Specific Aims: Specific Aim 1. We will follow up on our recent observation of a conformational effect of polyQ expansion transmited to an adjacent part of the molecule by undertaking systematic studies of monomer structure in response to polyQ repeat length. We will use fluorescent resonance energy transfer (FRET), solution NMR, hydrogen-deuterium exchange, and other methods to monitor structural changes in the monomer in response to sequence changes. Specific Aim 2. We will follow up on our recent observation of multiple structures of mature amyloid-like aggregates of htt NTFs to analyze these structures in atomic detail by solid state NMR and other methods. We will investigate whether polyQ repeat length or the extent and nature of the htt NT C-terminal Pro-rich region impart any significant structural differences on these aggregates. We will study in htt NTF aggregates the effects on structure of a double Ser to Asp mutation in the httNT sequence (S13D/S16D) that is known to abrogate the HD phenotype in a transgenic mouse expressing full length human htt with a Q97 repeat. Specific Aim 3. In this aim we will characterize the aggregation kinetics of htt NTFs, observing both overall rates as well as the kinetic lifetimes of non-amyloid intermediates. We will study the kinetics in response to differences in polyQ repeat length over the Q3 to Q42 range and inquire whether there is a sharp increase in rate at or near the pathological repeat length transition between Q36 and Q40. We will determine the rates of formation and aggregate morphologies of expanded polyQ forms of full length htt exon1 and compare them to a C-terminally truncated htt NTF containing a Pro10 sequence. Specific Aim 4. In this aim we will study the cytotoxicities and direct effects on mitochondrial viability of some of the htt NTF physical states we will generate in this grant. We will monitor overt cell death but will also explore more subtle, sub-lethal mitochondrial dysfunction in cells and isolated mitochondria treated with various htt NTF species. We will also study the ability of the aggregation inhibitor httNT to abrogate toxicity in a PC12 cell expressing an expanded polyQ version of htt exon1. The results of these studies should reveal characteristics of the alternative folded states of monomeric htt NTFs recently revealed by FRET studies, and the detailed structural and toxicity differences between recently discovered polymorphic forms of mature htt NTF fibril-like aggregates, including those that form in response to the disease-eradicating S13D/S16D httNT mutation. These studies should also reveal whether reducing polyQ repeats to sub-pathogenic lengths obliterates key disease-related biophysical properties. If not, this would suggest an approach to producing metastable aggregation intermediates in future studies.